Carolina Population Center

PROJECT SUMMARY/ABSTRACT
The Carolina Population Center requests infrastructure support that will advance population dynamics research
at CPC by increasing research impact, innovation, and productivity, supporting the development of junior
scientists, and reducing the administrative burden on scientists. Infrastructure support will advance science in
three primary research areas: Sexuality, Reproduction, Fertility, and Families; Population, Health, and the
Environment; and Inequality, Mobility, Disparities, and Well-Being. Much of the research at CPC draws on
large publicly available longitudinal data sets that our faculty have designed and collected, including the
National Longitudinal Study of Adolescent to Adult Health, the China Health and Nutrition Survey, newer
surveys associated with the Transfer Project, and the Study of the Tsunami Aftermath and Recovery, all of
which will continue to be important in work related to our primary research areas over the next five years.
These projects embody several themes that have guided research at CPC since the Center's inception. These
themes, which will continue to shape our work, are the importance of life course processes and longitudinal
data, multi-level processes and measurement of context, interventions and natural experiments as means of
learning about causal processes, and the relevance of sociodemographic variables such as age, gender, race-
ethnicity, and socioeconomic status for disparities in health and well-being. By embedding these themes, our
projects provide data that enable us to address barriers that otherwise impede progress in the population
sciences generally, and in our primary research areas in particular. We request support for three cores which
in combination will provide an institutional infrastructure that will push populations dynamics research forward
by empowering CPC faculty to tackle challenging questions using state of the art measurement techniques and
methods. The Administrative Core plans activities that maintain a stimulating intellectual community,
streamlines administrative processes so that scientists can focus on research, coordinates activities of the
Cores so that services are offered efficiently, and communicates information about research and data more
broadly. The Development Core supports early stage investigators and other faculty with exciting new ideas
through multiple mechanisms: workshops, access to technical expertise in measurement, and seed grants.
The Research Services Core enables scientists to address complex and important population research issues
by providing access to state-of-the-art research tools and professional support for programming, survey
development, and analysis.

Public health relevance
NARRATIVE This project will provide infrastructure support for a cutting edge program of research on population dynamics at the Carolina Population Center. Research at the Center will analyze state-of-the art data to address fundamental questions regarding fertility, adolescent health, and links between the environment and health. Special attention will be paid to factors creating health disparities.